TREATMENT OF HYPERANDROGENISM VS INSULIN RESISTANCE IN INFERTILE PCOS WOMEN

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. The subproject and investigator (PI) may have received primary funding from another NIH source, and thus could be represented in other CRISP entries. The institution listed is for the Center, which is not necessarily the institution for the investigator. The goal of this study is to compare improvement in insulin sensitivity (diet, lifestyle modification, weight loss) to improvement in hyperandrogenism (via OCP) and to improvement in both measures in terms of each interventions to result in pregnancy.